Next Generation Autologous TIL Cancer Therapy: Development of GMP manufacturing process

The overall goal of this Phase II SBIR grant proposal is to research and develop the GMP manufacturing
process for next-generation tumor infiltrating lymphocyte (TIL) cancer therapeutic for solid tumors. In clinical
trials, TIL-based immunotherapies have demonstrated tumor regression and increased survival rates against
different cancer types. Despite these encouraging clinical results, durable antitumor responses are typically
observed in a subset of patients with advanced cancers like melanoma. This stresses the need to develop
more effective TIL-based strategies and to expand efficacy against different cancer types. TIL therapies are
hindered in part by low TIL accumulation into tumors, low persistence, weak T cell receptor (TCR) affinity
and/or avidity as well as the low expression of tumor antigens on the cell’s surface. Additionally, the presence
of suppressive signals on T cells such as Lag3, Tim3, CD39, pose a major obstacle to generating effective and
long-lived antitumor T cell responses. In our published and preliminary studies, activating MyD88 signaling in
human or mouse T cells, increases antitumor activity and prolongs T cell survival. By fusing the high affinity
CD8α (extracellular) to MyD88 (intracellular; CD8α:MyD88) we have developed a novel and universal platform
that activates MyD88 signaling strictly upon the engagement of the TCR with the MHC-antigen on tumor cells.
CD8α:MyD88 expression in TILs cells substantially increases responses to weak and suboptimal levels of
tumor antigens including neoantigens, and in preliminary studies has demonstrated the extraordinary property
of reducing the T cells entry into an ‘exhausted state’. Importantly, the use of the CD8α co-receptor represents
a ‘universal’ approach to enhancing T cell responses, and can be used in patients regardless of the patient’s
HLA type. Through this SBIR Phase II application, we propose the following aims. Aim 1 will research,
develop, and manufacture GMP grade g-retroviral vectors. Here, we will generate high virus titer-producing
CD8a:MyD88-EGFRt PG-13 cell lines, accompanying analytical assays, and manufacture the GMP
CD8a:MyD88-EGFRt g-retroviral vectors. For this aim, we are partnering with a commercial contract
development manufacturing organization (CDMO), Vigene Biosciences to generate GMP viral vectors. In Aim
2, we propose to develop and manufacture GMP CD8a:MYD88 engineered TILs (coR8:AMPTM TILs). In
collaboration with the Gates Manufacturing Facility (GBF) at the University of Colorado Anschutz Medical
Campus (UCAMC) we will conduct process & analytical assay, QC release assay, develop and manufacture of
GMP grade coR8:AMPTM TILs. The successful completion of these aims will lead to the pre-IND and IND filings
with the FDA for a Phase I clinical trial in patients with immune refractory solid tumors. This activity will be
conducted in collaboration with the UCAMC’s Cell Therapy Operations Program (CTOP), Gates
Biomanufacturing Facility, and our team members who have extensive experience in cell therapy drug
development.

Public health relevance
Project Narrative T cell-based immunotherapies such as tumor infiltrating lymphocytes (TILs) have revolutionized the treatment of a number of different cancers including advanced melanoma. However, most patients still do not benefit from this form of therapy because few immune cells penetrate the tumor and show transient antitumor activity. We have developed a novel, genetically engineered TIL therapy that overcomes multiple impediments to conventional TIL therapy.